Alcohol and Stress: Interactive Effects

Depression is often described as a stress-related disorder, as it often occurs in the context of exposure to some form of stress. Indeed, alterations in HPA activity and regulation are one of the most consistently described biological abnormalities in depression and bipolar disorder. Stress can cause remodelling and microdamage in the brain, and can stimulate neuroinflammation. Moreover, significant risk factors for major depressive disorder are associated with increased inflammation; in turn, inflammatory mediators can induce depressive symptoms. In most cases, short-term stress-induced neuroinflammatory activation resolves, and the organism is then resilient in the face of later-life challenges. In the case of an organism with pre-existing vulnerability, such as occurs with PAE, short-term neuroinflammation may fail to resolve, and can progress to a more chronic condition, leaving the organism vulnerable to later life challenge. The present proposal will test the hypothesis that fetal programming of HPA activity by PAE results in altered neuroendocrine- neuroimmune interactions, giving rise to a sensitized, vulnerable organism, with an increased pro- inflammatory bias, that is predisposed to increased responsiveness to stressors or immune challenges later in life, resulting in increased vulnerability to stress-related disorders such as depression and anxiety. This hypothesis will be tested in three Specific Aims: 1) To determine the immediate or short-term effects of PAE and later life stress on depressive-/anxiety-like behavior and behavior mediated by the PFC, as well as markers of stress and neuroimmune function; 2) To examine the long-term effects of PAE and stress in adulthood or adolescence on depressive-/anxiety-like behavior and behavior mediated by the PFC, as well as markers of stress and neuroimmune function; and 3) To investigate the efficacy of antidepressant and anti-inflammatory treatments, separately or in combination, in attenuating or normalizing the adverse effects of PAE and later life stress and/or immune challenges on behavioral, brain, HPA and neuroimmune outcomes. Together, the data from these studies will have important implications for the development of novel therapeutic interventions for depression in individuals with FASD. RELEVANCE (See instructions): The present research utilizes our well-established animal model of prenatal alcohol exposure to examine the role of stress and neuroimmune abnormalities in mediating the increased incidence of depression observed in children with FASD. Our data will significantly increase our understanding of the mechanisms underlying the long-term consequences of prenatal alcohol exposure on health and well-being, and will have important implications for the development of novel therapeutic interventions for depression in individuals with FASD.